Research Network for the Harmonized Cognitive Assessment Protocol (HCAP): Years 6-10

PROJECT SUMMARY
The Harmonized Cognitive Assessment Protocol (HCAP) was designed by the HRS in consultation with
several of its international partner studies to provide a flexible yet comparable instrument for measuring
cognitive function among older adults around the world. Since 2016, the HCAP has been implemented in
fifteen studies around the world, and several studies in other countries are pilot testing the HCAP. The HCAP
thus provides unique research opportunities to exploit cross-country variations in key life-course factors that
likely affect risk for Alzheimer’s disease (AD) and AD-related dementias (ADRD), such as educational
attainment, wealth, retirement policies, diet, and the prevalence and treatment of cardiovascular risk factors.
However, cross-country variations also raise unique challenges for maintaining the harmonization of tests and
measures necessary for good comparative research. This application seeks to renew and build upon the
established HCAP International Research Network (U24 AG065182) that has facilitated harmonization of
methods and data across the international network of HCAP studies and supported the expansion of HCAP
studies to new countries.
Our first project period was extremely successful, as we contributed to the statistical harmonization of HCAP
measures across culturally, educationally, and linguistically diverse country settings, held in-person and virtual
meetings across HCAP study teams to facilitate collaborations and coordinate research approaches, and
funded pilot projects that provided insight to harmonization challenges, and expanded the global reach of the
HCAP data. Planned harmonization activities for the proposed renewal of the network span the full life-course
of such studies from sample design, to content and administration of the protocol, to statistical harmonization
of data collected, to diagnostic algorithms, to covariates for epidemiological research, including biomarkers and
genetics. While achieving harmonization in established studies requires active participation of senior
leadership, a main goal of the network is to continue developing younger scholars through facilitating
participation in network meetings, funding pilot studies, and supporting scholar exchanges among the studies.
We will build upon our previous successes and directly address harmonization challenges by disseminating
and incorporating the lessons learned in the prior project period. In addition to the exchange of information
through meetings and the network website, we will coordinate dissemination and educational outreach with
related networks focused on AD/ADRD and other networks harmonizing the HRS family of studies, including
the HRS Around the World Network, the Gateway to Global Aging Data, and the Population Studies of Aging
Biomarker Network.

Public health relevance
PROJECT NARRATIVE This proposal aims to renew and build upon the established Harmonized Cognitive Assessment Protocol (HCAP) International Research Network. Currently, fifteen longitudinal studies of aging have used the HCAP and several more intend to. By promoting common approaches to HCAP data harmonization and support of researchers using the data, the HCAP network will expand the resources and opportunities for studying AD/ADRD around the world.